Experimental evolution of Wolbachia-mediated dengue virus blocking in the mosquito, Aedes aegypti

PROJECT SUMMARY/ABSTRACT
The endosymbiont Wolbachia pipientis is being released into populations of the mosquito vector of
dengue, Zika, chikungunya and yellow fever viruses throughout the tropics. In the laboratory, Wolbachia
has been shown to “vaccinate” the vector, reducing or eliminating its ability to transmit viruses. One
concern for this biocontrol approach is that the mode of Wolbachia’s action remains unknown.
Additionally, as with all interventions (drugs, vaccines and insecticides), the emergence of resistance
may threaten the long-term efficacy of this endosymbiont. Here, we use powerful Evolve and
Resequence approaches in the mosquito, Wolbachia and in the virus to (1) understand the likely
mechanism of pathogen blocking, and (2) determine the most likely genetic paths through which
resistance will emerge in the mosquito and the virus. First, we will select for both improved and lessened
Wolbachia-mediated blocking of dengue virus in Wolbachia-infected mosquitoes; we have already
shown this is possible in a pilot study. In a fully replicated design, we will track the dengue virus load in
the mosquito and Wolbachia densities through time. We will perform RNAseq pre- and post-selection
and DNA sequencing throughout the regime on the lines as well as on random controls, demonstrating
changes in blocking. Via SNP and expression analyses, we will identify key genes associated with the
phenotypic shifts, in both symbiont and vector genomes, and develop a putative model for pathogen
blocking. In addition, we will have evidence of how it might be possible to improve the strength of
dengue blocking and the likely rate and diversity of evolutionary paths toward resistance. Through
selection experiments in cell culture, we will determine which aspects of the virus genome can confer
protection against the Wolbachia effect. By examining the fitness of the evolved mosquitoes and of the
evolved viruses, we will address the question of whether such variants would be competitive and pose
a real threat to evolution in natural environments. This work is novel in its application of real-time
evolution rather than a “sit and wait” approach to see how the relationships evolve in field sites. This
proactive strategy may help to design targeted strategies that circumvent the most likely forms of
resistance and demonstrate a means to improve upon the level of pathogen blocking exhibited by
current release strains.

Public health relevance
PROJECT NARRATIVE A bacterium called Wolbachia that “vaccinates” mosquitoes against pathogens is being released into the tropics as a possible means for limiting human infections with dengue, Zika and other viruses transmitted by the mosquito. The long-term efficacy of this strategy will be limited if resistance against Wolbachia evolves in either mosquitoes or the virus. Here, we use laboratory evolution experiments to understand both how the “vaccination” works and how resistance is likely to evolve so that effective counter resistance strategies can be developed.